FACULTY DEVELOPMENT PROJECT IN MENTAL HEALTH RESEARCH

The purpose of the proposed project is to complement and reinforce the existing faculty development infrastructure at Morehouse College. The project is designed to improve the ability of selected faculty in psychology, sociology and biology to conduct alcohol, drug abuse, and mental health (ADM) research and to expose faculty in other social and natural sciences to opportunities and resources for ADM research in their fields. All participating faculty have done some research and remained fairly current in their fields despite heavy teaching loads. Most have worked in ADM areas, but conducting nonfunded or minimally funded research. The proposed project is intended to support and develop that potential and to tap the interest of other appropriate sciences on campus in ADM research. Morehouse has begun to address the needs cited about through supporting a comprehensive faculty development program and creating a faculty resource network. The present effort will capitalize on the initial investment by providing additional contexts, specifically related to ADM research, for reinforcing these features of the existing faculty development program. The proposed Morehouse Faculty Development Project in ADM Research consists of two components: (1) Institutional Research Development and (2) Individual Investigator Research Projects. The principal features of Institutional Research Development include didactic seminars, consultation and training, and release time.